Developing a Framework to Advance Cultural Sensitivity and Accommodate Behavioral Variability in Toddler Autism Screening: A Mixed-Methods Cross-Cultural Approach to Improve Autism Screening Accuracy

PROJECT SUMMARY
Autism Spectrum Disorder (ASD) is a prevalent, lifelong condition that manifests early in life and is associated
with significant social communication challenges1–3 and economic needs1 for children with ASD and their
families. Access to early, ASD-specific services can profoundly improve long-term outcomes for children with
ASD4–9 and depends on timely detection of the condition. However, the predictive accuracy of ASD screening
is well below recommended standards for screening tools10,15,21 and is even lower for racial and ethnic minority
children10,31–38 when compared to White children. Screening tools, which typically rely on parental report, may
lack predictive accuracy because they do not sufficiently account for heterogeneity between and within
cultural groups. Variation in culture-based parental perception of early ASD expressions has been noted
between groups29,46–51, and some social communication behaviors used in ASD screening perform significantly
differently between racial and ethnic groups31,32,36–38. Additionally, existing phenomenological heterogeneity has
been observed via clinicians in the development of social communication emergence across prodromal
individuals44, 53–58 within cultural groups. However, current screeners employ methods that do not sufficiently
capture this existing heterogeneity, and this heterogeneity has not been precisely characterized as
prospectively observed and reported by caregivers. Therefore, it remains difficult to develop new parent-report
screeners designed to account for heterogeneity in developmental trajectories in an informed way.
The primary objective of this proposal is to develop and assess a framework for developing culturally-sensitive
and highly predictive parental-report screening measures to improve the equity and accuracy of future ASD
screeners for use with diverse families. This will be achieved by i) developing culturally-sensitive ASD
screening items; ii) using these items in data collection via ecological momentary assessment (EMA); and iii)
employing Machine Learning (ML) to develop prototype algorithms that maximize ASD prediction between and
within different cultural groups. EMA provides real-time in-context monitoring at time-periods proximal to target
dynamics60–62. EMA is therefore an ideal choice to capture the heterogeneity in developmental trajectories of
social-communication behaviors over time as observed and reported by caregivers. ML develops prediction
algorithms that can differentially weigh and combine ASD indicators based on group affiliation, individual
differences, and temporal specificity and is an optimal approach for algorithm development in the presence of
developmental heterogeneity76 but is underutilized in ASD screening efforts77. Through the proposed research
and training plan, the applicant will develop the skills and expertise needed to make a substantive contribution
to ASD research as an independent clinical scientist.

Public health relevance
PROJECT NARRATIVE This proposal will develop and assess a framework for developing culturally-sensitive and highly predictive parental-report screening measures to improve the equity and accuracy of future ASD screeners. Current ASD screeners do not sufficiently account for i) heterogeneity between cultural groups in culture-based parental perceptions of early Autism Spectrum Disorder (ASD) expressions and ii) heterogeneity within cultural groups in the development of social communication behaviors over time, which together impede equitable and accurate ASD screening and timely access to ASD-specialized services. This proposal will apply mixed- methods data collection and analytic techniques in a novel manner to precisely characterize this dual heterogeneity and to develop prototype algorithms that predict ASD in diverse families.